T cell immunity to CMV in utero and in early childhood

Abstract:
CMV infection in utero leads to prolonged viremia and often devastating clinical sequelae. In adults, it is
established that the T cell response to CMV is required for containment of viremia. However, the immunologic
determinants of viral control and clinical sequelae following congenital CMV infection are not known. In this
project, we will study the immune response to CMV as a window into immune ontogeny and the age-related
maturation of antiviral T cell function. We will leverage a large cohort of mother-infant pairs with samples
banked longitudinally for immunologic studies. This cohort, which includes a large number of infants infected
with CMV in utero and others infected during early childhood, affords a unique opportunity to examine the
relationship between the age-related maturation of the immune system and control of CMV viremia. Prior
studies have shown that two populations of cytotoxic T lymphocytes, CD8 T and gd T cells, expand and
differentiate upon CMV infection in utero. We hypothesize that T cells generated during fetal development
(including both CD8 and gd T cells) are intrinsically biased toward rapid differentiation into terminal effector
cells. We further hypothesize that this effector-biased programming limits the ability of infant CD8 T cells to
generate the long-lived memory sub-populations that are required for sustained control of a chronic viral
infection. This hypothesis is supported by data from experimental murine models but has not been fully
examined in human infants in the context of a natural pathogen. While the CD8 response continues to mature
postnatally, gd T cells develop earlier in gestation and exhibit many innate-like qualities that could enable them
to act as important antiviral effectors in utero. Remarkably, gd T cells that express CMV-reactive gd TCRs and
pre-programmed effector functions are already present in the fetal thymus at mid-gestation. These fetal gd T
cells can be rapidly activated to produce IFNg and granzymes upon stimulation. Hence, we hypothesize that
fetal gd T cells play an important role in mediating anti-CMV effector functions in utero, while the adaptive ab T
cell response matures. In the first two aims, we will compare gd and CD8 T cell responses in congenitally CMV-
infected newborns to those of children who acquire primary CMV infection during the second year of life, in
order to identify critical pathways of immune maturation. CD8 and gd T cells will be assessed by high-
parameter cytometry, functional assays, and paired transcriptional and TCRseq profiling of individual cells in
order to identify differences in the response to CMV based on the developmental window during which
infection occurred. In Aim 3, we will relate these immunologic parameters to clinical sequelae and the
resolution of viremia during infancy in order to identify immune correlates of viral containment. Understanding
how variability in the infant immune response to CMV relates to clinical and virologic outcomes, and how age-
related differences in this immune response enable the gradual resolution of viremia postnatally, could lend
great insight into antiviral T cell function in early life.

Public health relevance
Project Narrative Congenital infection with cytomegalovirus (CMV) is a leading cause of childhood deafness and permanent neurologic impairment worldwide, with approximately 40,000 cases occurring annually in the U.S. This project will include detailed studies of CMV-specific immunity in infants infected in utero and in early childhood and will identify immune correlates of viral control and clinical sequelae. Insights from these studies will lead to a better understanding of the cellular and molecular immune processes that underlie the age-related vulnerability of the human fetus to viral infection.